Aneuploidy and Acquired Antifungal Drug Resistance in Candida species

ABSTRACT
Antifungal drug resistant Candida species pose an urgent antimicrobial threat worldwide. Patients with invasive
Candida infections experience high mortality >40%, despite the use of modern antifungal therapies. Only three
drug classes are frequently used to treat Candida infections: azoles, echinocandins, and polyenes. Resistance
to all three classes is increasing. The acquisition of antifungal drug resistance is frequently associated with large
genomic copy number changes in diverse fungal pathogens, including Candida species. We identified novel
large accordion-like DNA amplifications in C. albicans that rapidly expand during adaptation to azoles in vitro,
amplifying hundreds of genes to more than 10 copies. We also reported that 50% of azole resistant C. albicans
clinical isolates are aneuploid, and that Candida auris aneuploids can evolve during on-patient antifungal
therapy. Aneuploidy is also associated with antifungal tolerance, a poorly understood phenotype that enables
Candida to grow slowly at high concentrations of all three drug classes, well above the minimum inhibitory
concentration. We propose that aneuploidy-mediated antifungal tolerance is promoting the evolution of antifungal
resistance. Despite the frequency of aneuploidy, the rate and dynamics of chromosome copy number changes
during adaptation to antifungal drug are not known for any fungal pathogen. We developed several high
throughput single-cell and population-level approaches to comprehensively quantify the emergence and spread
of all genomic changes during the acquisition of antifungal resistance, in real time. Our multidisciplinary approach
uniquely positions us to identify new mechanisms of acquired antifungal tolerance and resistance in a rigorous
and reproducible way. For example, we identified the sterol biosynthesis pathway as a hotspot for acquired
multidrug resistance and tolerance across diverse Candida species, creating a paradigm shift: Multidrug
resistance can evolve during adaptation to a single antifungal drug class, due to acquisition of a single point
mutation. The aims of this proposal take a new approach to identifying the mechanisms driving antifungal drug
resistance: We will use a new single-cell flow cytometry assay to quantify the rate and dynamics of aneuploid
events during adaptation to each drug class and determine the effect of drug class on the evolution of drug
resistance (Aim 1). We will comprehensively identify genes that when amplified alter drug susceptibility in vitro
and in vivo using a novel CRISPR-amplification approach (Aim 2). Finally, we will use comprehensive molecular
approaches to determine the degree to which mutations in the sterol biosynthesis pathway cause multidrug
resistance in diverse Candida species (Aim 3). This comparative analysis of acquired resistance will provide a
strong foundation for work in other Candida species. Together the outcomes from these experiments will identify
the mechanisms that underlie how Candida species acquire drug tolerance and resistance and can pave the
way for developing therapeutics to reduce the significant mortality caused by diverse antifungal drug resistant
Candida species.

Public health relevance
PROJECT NARRATIVE Candida species are the 2nd most common cause of all hospital acquired bloodstream infections and the mortality of these infections can reach 40% even with antifungal drug therapy. The goal of this project is to determine how antifungal drug resistance evolves by tracking the rate, order and effect of growth promoting mutations. We will employ experimental evolution, mathematical modeling, comparative genomics, and molecular engineering to identify new molecular mechanisms driving the rapid evolution of drug resistance in diverse Candida species.